Partners IN CONTROL: Using Remote MonitorINg teChnology with cOmmuNity healTh woRkers to support hypertensiOn management for Latinx patients

Latinx adults experience a disproportionate burden of cardiovascular disease in the United States, driven in part
by structural barriers to accessing and utilizing care. Latinx patients are at risk for hypertension (HTN), and are
less likely to be able to access necessary care to manage this condition. Digital health tools such as remote
patient monitoring (RPM) have potential to improve the care of Latinx patients with HTN by enabling more
frequent and tailored monitoring of blood pressure, providing additional health information, empowering patients,
and enhancing care decision-making without disrupting patients’ daily lives. However, there are significant
disparities in the access and use of these digital tools, as well as challenges to equitable and sustainable
implementation. To mitigate these disparities, there is urgent need to identify methods to equip and facilitate the
implementation of RPM for diverse populations and address social, structural, and digital determinants of health
to make RPM care more appropriate for diverse patient needs. Community health workers (CHWs) are
specifically trained to address social and structural determinants of health to help patients manage health
conditions, provide culturally and contextually competent support, and navigate complex health systems; “tech-
enabled” CHWs have potential to be catalysts for improved RPM use for Latinx patients. Our team – comprised
of leaders of RPM implementation and infrastructure, CHW training, informatics, digital health, quantitative and
qualitative study design, data analytics, and health disparities research – seeks to determine if the addition of
RPM-enabled CHWs provided with specific training and EHR support tools can improve HTN control and reduce
inequities among Latinx patients with uncontrolled HTN. Specifically, we seek to: 1) develop adapted community
health worker remote patient monitoring training modules (“CHW RPM”) and electronic health record support
tools (“CHW RPM-EHR") guided by the CFIR model to enhance the management of hypertension in Latinx
patients; 2) evaluate the effectiveness of RPM-enabled CHWs compared to standard of care RPM hypertension
management on blood pressure reduction among 300 Latinx patients with uncontrolled hypertension; and 3)
apply Proctor’s Implementation Outcomes Framework (IOF) to evaluate the implementation of the RPM-enabled
CHWs for HTN management, and examine adoption, acceptability, fidelity, cost, sustainability, and equity as
mechanisms of implementation effectiveness. The primary outcome will be improvements in HTN management
at 12 months. We will utilize a mixed methods approach – including EHR-based data review, patient surveys, in-
depth interviews with PCPs, RNS, CHWs, and patients – novel consensus-building, user-centered design and
agile development techniques, and theory-driven implementation assessment frameworks to assess the
intervention. This research will help inform RPM implementation for our diverse patient population, as well as
offer larger insights into to the opportunities and challenges of using CHWs to expand access to RPM to Latinx
patients and ultimately improve health equity.

Public health relevance
Project Narrative Digital health technologies such as remote patient monitoring (RPM) have potential to improve the care of Latinx patients with hypertension (HTN), but there are barriers to both effective and equitable use in clinical practice and a need for better approaches in this population. Growing evidence supports the addition of community health workers (CHWs) to primary care teams as effective means to address social and structural determinants of health and healthcare needs to improve HTN management among Latinx patients, and supporting their digital health competency and capacity may enable improved implementation and sustained use of RPM technology. This study seeks to enhance implementation and effectiveness of RPM among Latinx patients with uncontrolled HTN using CHWs supported by advanced RPM training and EHR support tools.